Enhancing Speech Processing In A Rat Model Of Autism Using Vagus Nerve Stimulation

One of the major obstacles facing individuals with autism is the inability to communicate effectively. While there
are many reasons for this inability, an important component appears to be a serious deficit in the ability to process
speech sounds effectively. Expensive, time-consuming behavioral interventions can improve behavioral
outcomes, but many individuals undergo these interventions and still experience deficits. The development of
adjunctive interventions that can increase the benefit of rehabilitation therapies is essential to improve the lives
of individuals with autism spectrum disorders (ASD). We have developed a novel technique to drive robust
neuroplasticity and enhance the benefits of rehabilitation. Vagus nerve stimulation (VNS) paired with the
presentation of a sound triggers rapid, phasic release of plasticity promoting neuromodulators, which potentiate
plasticity in the auditory network. Recent preclinical and clinical findings indicate that VNS paired with sensory
or motor rehabilitative therapies can significantly enhance functional recovery compared to rehabilitative therapy
alone. This proposal will evaluate whether VNS paired with auditory training can enhance the efficacy of
rehabilitation in the context of autism. In utero valproic acid (VPA) exposure is a well-documented cause of
autism in humans. Similar to individuals with autism, both speech discrimination ability and auditory cortical
responses are impaired in VPA exposed rats. The objective of this proposal is to determine whether VNS paired
with auditory training can reverse the neural and behavioral auditory processing deficits observed in VPA
exposed rats. In Aim 1, we test the ability of both implanted and non-invasive VNS paired with auditory training
to improve discrimination ability after prenatal VPA exposure. VPA exposed rats are significantly impaired at
discriminating between speech sounds. We will evaluate discrimination accuracy in VPA or saline exposed rats
undergoing VNS paired auditory training. In Aim 2, we evaluate awake behaving neurophysiological responses
in auditory cortex to evaluate the VNS-dependent neural plasticity that may underlie improved auditory
processing. VPA exposed rats exhibit altered auditory cortex responses compared to control rats. Previous
results suggest that VNS pairing may strengthen auditory cortex responses more rapidly and to a greater degree
than training alone. In Aim 3, we test the role of two neuromodulatory networks in the VNS-dependent
enhancement of plasticity and sound discrimination ability in the context of VPA exposure. We will deplete
cholinergic or noradrenergic afferents specifically to the auditory cortex to determine whether acetylcholine or
norepinephrine depletion impairs VNS-related improvements in auditory processing. In addition to proof-of-
concept evidence for clinical translation, this proposal will provide insight into the ability of plasticity-based
therapies to be effective in treating ASD and lay the groundwork for more comprehensive future studies, with the
goal of translating these critical first-in-animal preclinical experiments to a clinical therapy that could provide
significant, tangible improvements in the lives of individuals with ASD.

Public health relevance
One of the major obstacles facing individuals with autism is the inability to process speech sounds effectively. Extensive training can yield modest improvements in speech perception and cortical plasticity, but gains are often limited. The development of adjunctive techniques to enhance neuroplasticity and increase the benefit of auditory rehabilitation is essential in order to improve the lives of individuals with communication impairments.